Ischemic Stroke in Cerebral Amyloid Angiopathy: Microvascular Injury and Recovery

Project Summary
Recovery after ischemic stroke is one of the most critical rehabilitative medical problems in
medicine. While current treatments are effective in removing clots, most patients do not present to hospitals
before serious tissue damage occurs in the brain, with as many as two-thirds of stroke survivors
requiring neurorehabilitation. Furthermore, post-stroke outcomes have been poorly studied in patients
with cerebral amyloid angiopathy (CAA). CAA is a form of cerebrovascular disease and is characterized by
substantial beta-amyloid (Aβ) accumulation within cerebral vasculature, including the blood-brain barrier
(BBB). This condition exceeds amyloid deposits associated with normal aging and may contribute to age-related
neurological decline. Additionally, Aβ accumulation in CAA is a risk factor for ischemic infarcts and degradation
of vessel wall architecture. The integrity of vessel wall architecture is crucial for post-stroke tissue recovery since
many proliferative neural progenitor cells (NPC) are close to and communicating with cerebral vasculature (BBB).
This pool of proliferative NPCs that can become depleted by stroke can be mutually affected by Aβ accumulation,
leading to delayed recovery of both motor and cognitive functions. We aim to understand the mechanism behind
delayed post-stroke recovery because of both conditions so that targeted therapies can be proposed in the
future.
To study this, we will employ a transgenic 5xFAD mouse model that recapitulates Aβ accumulation in the brain
to analyze CAA and cerebrovascular ischemia. The central hypothesis of this study is that Aβ accumulation in
cerebral vasculature exacerbates ischemic stroke outcomes and delays post-stroke recovery by inducing BBB
dysfunction and aberrant neurogenesis of NPCs. Experiments will focus on neurogenesis post-stroke, as well
as microvascular function and the bioenergetic mechanisms that induce it. While there is no effective strategy to
treat tissue damage following ischemic stroke and/or treat Aβ accumulation in the brain, this project focuses
on the mechanism of CAA-related stroke in order to develop therapeutic strategies in the future. Defining
neuropathogenesis of both CAA and ischemic stroke incidents is of significant relevance in translational medicine
and clinical practice because most patients diagnosed with Alzheimer’s Disease (AD) also present with
CAA; therefore, most of the disease burden due to CAA can be clinically relevant to treatments that also affect
AD.

Public health relevance
Project Narrative The proposed research will study the mutual effect of amyloid-related brain injury and ischemic stroke on cerebrovascular recovery. Since dementia outcomes are a national health crisis, understanding the effects of elevated Aβ on vascular and neuronal dysfunction will provide insight into their synergistic effects on post-stroke recovery and cognitive decline. Elucidating the mechanism that drives dysfunction of the blood-brain barrier and neural progenitor cells may help us develop therapeutic strategies to reduce the burden of neurological disease in CAA, stroke, and even clinical Alzheimer’s Disease.